HSR&D Research Career Scientist Award

Dr. Hamilton is an accomplished researcher who has made pioneering theoretical, methodological, and
empirical contributions to implementation and health services research related to the care, needs, and
experiences of vulnerable populations. Funded by VA HSR&D, QUERI, and VA Women’s Health Services, her
current portfolio focuses on women Veterans’ healthcare utilization and decision-making, implementation of
gender-tailored care for women’s high-priority health conditions, and attrition and retention in the VA women’s
health workforce. She also provides training and mentoring nationally on implementation science, particularly
evidence-based quality improvement (EBQI), a strategy that emphasizes multilevel stakeholder engagement in
local change processes. Dr. Hamilton is strongly committed to the quality and conduct of health services and
implementation research, consistently developing and testing tailored qualitative and ethnographic methods for
rapid turn-around projects with high demand for policy-relevant deliverables.
The goal of this application is to provide support for an established investigator to expand her current lines of
partnered research on women Veterans’ health, EBQI, and employee engagement, and to advance rapid,
rigorous methods that are well-suited for implementation science. Dr. Hamilton has a track record of mentoring
trainees at multiple levels and extensive collaborations with other investigators and VA operations partners.
The proposed award will enhance her ability to mentor and train to early-stage and established VA
investigators, and enable her to embark on new and innovative areas of investigation related to women
Veterans’ health, multilevel stakeholder engagement, and dissemination of research findings to a wide variety
of VA constituents, including policy-makers and Veterans.

Public health relevance
This career award focuses on partnered research about women Veterans’ health and health care as well as approaches to strengthening the healthcare system by supporting providers and staff. The current and planned research portfolio focuses on understanding women Veterans’ healthcare utilization and needs, and implementing flexible, patient-centered care models. Engaging stakeholders (e.g., leaders, staff, Veterans) in the care transformation process is central to the research. The career award enables continuing service to VA as well as mentoring and training early-stage and established investigators in designing, conducting, and disseminating high impact research that will result in improved quality of care for Veterans.